RELATIONSHIP OF NEUROBEHAVIORAL AGING WITH RISK FACTORS

The purposes of this study is to determine whether neurobehavioral performance in healthy older people is associated with the presence of risk factors and/or functional abnormalities in cerebral an cardiovascular function.